Biostatistics and Data Management Core

PROJECT SUMMARY – Biostatistics and Data Management Core (Core C)
The translational Research Projects proposed in this P20 planning grant integrate many different types of existing
and newly generated data, including biological, clinical, demographic, genomic, metabolomic, imaging, and
neighborhood variables. The Biostatistics and Data Management Core (Core C) functions as a centralized
research design and data science coordination center for all P20 Projects, bringing together expertise and
intellectual resources in biostatistics, bioinformatics, geospatial data analysis, and data management for all P20
investigators. Core C will provide the statistical and data science infrastructure needed for development
of a future SPORE application upon completion of the P20 planning grant. Core C members will: 1) provide
biostatistical and bioinformatics support for rigorous research design and state-of-the-science statistical
analysis for all P20 Projects and the Developmental Research Program (DRP); 2) facilitate state-of-the-science
geospatial data analysis for all P20 Projects and the DRP; and 3) develop and maintain an integrated database
environment for efficient data management, integration, analysis and sharing for all P20 Projects, the DRP
and investigator-initiated inquiries. Core C members will work collaboratively with investigators to ensure that
the appropriate design is incorporated into all studies from inception, that data are appropriately validated, linked,
cleaned and analyzed, and that all results will be interpreted for statistical as well as biological/clinical
significance. The Biostatistics and Data Management Core will work with the Administrative Core (Core A) to
assist in preparation of reports, data management and other administrative duties; and with the Biospecimen
Processing and Storage Core (Core B) for management and analysis of specimen-related data. Fully integrating
Core C members into all P20 Projects and other Cores will build workflow efficiencies and support the
translational goals of the P20, while enhancing quality and ensuring scientific integrity of participating Projects.
Core C will provide sophisticated data management, design, and analysis services in order to facilitate important
discoveries about acute lymphoblastic leukemia ethnic disparities and to guide future prevention and intervention
strategies.

Public health relevance
NARRATIVE – Biostatistics and Data Management Core (Core C) Latino children with acute lymphoblastic leukemia (ALL) have greater treatment-related toxicities compared to other ethnicities. A complex array of factors at multiple levels likely contributes to disparities in treatment-related toxicities and treatment outcomes. The Biostatistics and Data Management Core will provide sophisticated data management, design, and analysis services in order to facilitate important discoveries about ALL disparities and to guide future prevention and intervention strategies.